Food and Resources Expanded to Support Health and Type 2 Diabetes (FRESH-T2D)

In 2020, more than 38.5 million (10.5%) U.S. households were without reliable access to sufficient quantities of
affordable, nutritious food due to limited money or other resources. Food insecurity, poor nutrition, and economic
disadvantage are critical social determinants of health that contribute to disparities in type 2 diabetes mellitus
(T2DM), a serious diet-sensitive chronic disease affecting more than 20% of food insecure adults. Coping
strategies favor inexpensive, ultra-processed foods that substantially diminish diet quality and are associated
with increased incidence and severity of T2DM, including poorer glycemic control and excess body weight. Given
that numerous social factors and systems contribute to and perpetuate food insecurity and poor diabetes
outcomes, there is a demonstrable need for multilevel (individual, household, community) food-focused
interventions to effectively and sustainably address the diet quality of persons with, or at risk of, T2DM. To our
knowledge, no studies have rigorously tested whether intervention programs explicitly designed to improve both
food and nutrition security of low-income persons with T2DM are feasibly delivered by personnel at a Federally
Qualified Health Center (FQHC), acceptable to patients seeking care in their medical home, or are capable of
producing clinically relevant changes in T2DM endpoints. These are questions we will explore in our proposed
randomized wait-list controlled pilot study— Food and Resources Expanded to Support Health and Type
2 Diabetes (FRESH-T2DM)— in which our previously developed food and diabetes self-management education
(DSME) intervention (FRESH) will be delivered to 50 adult FQHC patients with T2DM and food insecurity
twice monthly, for 6 months. The FRESH intervention consists of bimonthly food provision; a series of recipes
that feature FRESH foods; diabetes self-management education (DSME) resources; and four, 30-minute visits
with an FQHC Registered Dietitian Nutritionist and Certified Diabetes Educator who will help participants utilize
FRESH resources to meet personalized treatment goals. We will build upon our prior work and existing
collaborations with colleagues at El Rio Community Health Center, a Federally Qualified Health Center serving
>110,000 underinsured, uninsured patients and the Community Food Bank of Southern Arizona, a regional
food bank serving 180,000 Arizonans across 5 counties to: (Specific Aim 1) Assess the feasibility, acceptability,
and participant uptake of our FRESH intervention, delivered to 50 food insecure adults with T2DM at their medical
home, El Rio Community Health Center, and (Specific Aim 2) Explore changes in blood glucose control, diet
quality, food security, diabetes self-care behaviors, and health-related quality of life among participants at 3 and
6 months. Completion of our pilot study —submitted in response to NIDDK PAS-20-160 —will produce data to
inform the rationale and design of a future definitive randomized controlled clinical trial, including recruitment,
retention, adherence, and cost data. Our long-term goal is to produce a tested, efficacious model of coordinated
care capable of replication and scaling across other FQHCs and food bank networks.

Public health relevance
Food insecurity, poor nutrition, and economic disadvantage are critical social determinants of health that contribute to disparities in type 2 diabetes mellitus (T2DM), a serious diet-sensitive chronic disease affecting more than 20% of food insecure adults. There is a demonstrable need for food-focused interventions to address the diet quality of persons with, or at risk of, T2DM. Completion of our pilot study will produce recruitment, retention, adherence, and cost data for a future definitive randomized controlled clinical trial, bringing us closer to our long-term goal of a tested, efficacious model of diabetes care coordinated across Federally Qualified Health Centers and food bank networks.